Contraceptive Autonomy: A Mixed-Methods Approach to Developing a Novel Family Planning Measure

Project Summary
Contraceptive autonomy – people’s ability to decide for themselves what they want in regard to contraceptive
use, and to realize that decision – is essential for reproductive health and wellbeing. The primary goal of this
proposal is to develop, refine, and test a contraceptive autonomy indicator that measures the extent to which
family planning programs respect and promote free, full, and informed contraceptive decision-making. The
longer-term objective of this research is to incorporate a concise survey module for this indicator into existing
population-based surveys for routine, standardized, and comparable monitoring across time and place.
Improved measurement of contraceptive autonomy can create new health systems incentives for respectful,
rights-based family planning.
Specific aims of this project include 1) Developing a novel contraceptive autonomy indicator that maximizes
information and minimizes respondent burden via formal psychometric analysis of novel survey data from
Burkina Faso; 2) Assessing the transportability of “contraceptive autonomy” across diverse sociocultural
contexts; and 3) Test and refine the updated autonomy indicator in Nepal and Kenya with cognitive interviews.
To meet Aim 1, the PI will use a first-of-its-kind dataset from Burkina Faso with novel survey questions on
informed contraceptive decision-making, full access to a broad contraceptive method mix, and free
contraceptive choice. To achieve Aims 2 and 3, the PI will collaborate with leading researchers in Nepal and
Kenya to collect new data, using semi-structured in-depth and cognitive interviews with a diverse sample of
women to understand how notions of autonomy differ across context, and gather pilot data to inform a future
multi-site validation study.
The goal of the training and career development portion of this grant is to foster the independent research
career of Dr. Leigh Senderowicz. Dr. Senderowicz is an emerging scholar of patient-centered family planning
and global health metrics. With the guidance of mentors Dr. Daniel Bolt, Dr. Jenny Higgins, Dr. Corinne Rocca
and Dr. Claire Wendland, Dr. Senderowicz will pursue a program of training in latent variable modeling,
transnational comparative qualitative analysis, survey scale-up and research translation, and professional
development at the University of Wisconsin-Madison. These training activities will grow her methodological
repertoire and enhance her career as an independent reproductive health scholar. The proposed research is
poised to make a substantial impact on global reproductive health, helping to expose reproductive health
disparities, and provide new data to inform equitable, person-centered reproductive health programs.

Public health relevance
Project Narrative Lack of contraceptive autonomy is associated with health inequities and adverse health outcomes ranging from STIs to depression to low birth weight. However, without the tools to measure contraceptive autonomy, researchers and policymakers are left without a clear idea of where and how contraceptive autonomy is lacking, and which sociodemographic groups are most affected. The study proposed here will develop and validate a standardized metric of contraceptive autonomy, documenting reproductive inequities and situating the multidimensional construct of autonomy within cultural context.